DOGSURF: Database Optimized for Graph Search Using Robust Federation

Abstract
The Translator project has made substantial progress in the area of biomedical data integration
and question answering, evolving from a feasibility study to its current development phase. This
proposal builds on prior progress made collaboratively between the Exploring Agent and
Service Provider teams, and between those teams and the rest of the Translator Consortium.
Our proposal, entitled "DOGSURF: Database Optimized for Graph Search Using Robust
Federation" will further advance the project into the Performance Phase, focusing on
architectural standardization and centralization, improved performance and result quality, and
expanded functionality. The proposal is organized around three Specific Aims:
1. Expanding the BioPack Framework: This aim involves enhancing BioPack, a modular
framework for querying the Translator Knowledge Graph (KG) and improving result scoring and
organization. Collaboration with the DOGSLED team will focus on the Retriever and Shepherd
components to boost performance and functionality.
2. Enhancing the BioThings SDK and BioThings Explorer: Leveraging BioPack, the project
will extend the BioThings SDK and improve the BioThings Explorer. This includes enhancing
answer quality, introducing new query types, and improving performance through integration
with BioPack.
3. Building High-Performance Central Components: The final aim focuses on developing a
unified backend infrastructure and access interface. This includes consolidating data ingestion
backends, unifying services like Annotator and NodeNorm, and creating a centralized interface
for efficient access across the Translator ecosystem.
User engagement is central to
the proposal, with a plan to collect
feedback, prioritize features, and
increase usage by the research
community. Collaborations with
external bioinformatics cores will
further expand Translator's
impact. The project plan provides
detailed annual milestones for
each Specific Aim for five years.
Key abbreviations
ARA: Autonomous Relay Agent – Translator
components responsible for reasoning
BSDK: BioThing SDK – a framework
developed by our team to efficiently create
high-performance APIs
BTE: BioThings Explorer – an ARA developed
by our team for reasoning on a federated KG
DOGSLED: Data, Ontologies, and Graphs to
Support Learning and Enhance Development
– the name of another team with whom the
BioPack vision and plan was developed
DOGSURF: Database Optimized for Graph
Search Using Robust Federation – the name
of the project described in this proposal
ITRB: Information Resources Technology
Branch – the branch of NCATS responsible
for provisioning computational resources
KP: Knowledge Provider – Translator
components responsible for providing access
to information from knowledge sources
KS: knowledge source – a generic term for a
resource that provides useful and relevant
data to Translator
SDK: Software Development Kit – a set of
programmatic tools and libraries to efficiently
create and extend software applications